Psychosocial and Neural Mechanisms for a Culturally and Linguistically Adapted Treatment for Bilingual Latino Young Adults with Autism

Project Summary/Abstract
Candidate: This K99/R00 Pathway to Independence Award proposal aims to provide me with the training
needed (K99 phase) to execute mental health clinical trials (R00 phase) for Latinos with autism spectrum
disorder (ASD) during their transition to adulthood.1 My preliminary community-based participatory research
work2 found that Latinos with ASD may benefit from culturally adapted programs to help build skills to manage
mental health, executive functioning, and socialization.3 As my research progressed, I became interested in the
neural biomarkers that illustrate mechanism of treatment response. These experiences helped shape the
direction for this K99/R00 proposal, which aims to complete the necessary research and concurrent training
(K99) to conduct a randomized controlled trial (RCT) of a culturally and linguistically adapted therapy program
(¡Iniciando! la Adultez)4 for Latino young adults with ASD and their Spanish-speaking parents. This proposal
will also allow me to learn how to identify neural mechanisms of action (R00). To accomplish the goals for this
K99/R00 project, I will complete training in: 1) implementation science to improve mental health disparities for
Latinos with ASD, 2) RCT design and execution, 3) advanced neuroimaging, and 4) professional development.
Research: Young adults with ASD transitioning to adulthood (18-25 years old) in the United States experience
the highest rates of co-occurring depression or anxiety when compared to the general population.5 The
pandemic
access
yet
for
recent
highlighted underlying systemic disparities facing Latino young adults with ASD, including limited
to mental health care 6. Culturally adapted and translated i nterventions are significantly more effective,
it is disappointing that l ittle evidence examines the promise of treating co-occurring mental health disorders
Latinos. Latinos are also not represented in research that could help accelerate clinical interventions
7
8–11
(i.e., neural and psychosocial mechanisms of action).12 Neural and psychosocial mechanisms of action have
the power to enhance treatment efficacy, optimize therapeutic personalization, and scientific validation.13,14 The
dearth
and
of research evaluating ulturally adapted and translated interventions from a multimodal (e.g., neural
psychosocial) perspective maintain long-term health inequities for Latinos with ASD.
c
11,15,16To address the
need to identify the neural and psychosocial mechanisms of action for culturally-adapted treatments for Latinos
with ASD and their Spanish-speaking parents during the transition to adulthood, I will 1) finalize the culturally
adapted and translated ¡Iniciando! program (Aim 1a) and neuroimaging protocol (Aim 1b), 2) conduct a RCT of
the ¡Iniciando! through telemedicine technology by community health workers and therapists with Latino young
adults with ASD and depression or anxiety and their Spanish-speaking parents (n = 100 dyads), and 3) identify
potential neural and psychosocial mechanisms of action for a subset of young adults (n = 60) from the RCT.
This K99/R00 research and training plan is in line with NICHD's priorities and cross-cutting topics to improve
Latino adolescent physical and mental health functioning during the transition to adulthood.

Public health relevance
Project Narrative This project builds on my past research and current community partner relationships to produce a culturally adapted and translated, evidence-based therapy (¡Iniciando! La Adultez) program for Latino young adults (18- 25 years old) with autism spectrum disorder (ASD). The intervention focuses on the transition to adulthood and includes Spanish-speaking parents (K99 phase). During the R00 phase, I will complete a randomized controlled trial of the ¡Iniciando! program and evaluate and identify potential neural and psychosocial mechanisms of action that may explain treatment outcomes for 100 bilingual, Latino young adults with ASD.